CHRONIC GVH DISEASE IN RAT RADIATION CHIMERAS

Chronic graft-versus-host disease (GVHD) is a frequently debilitating and often fatal complication in recipients of allogeneic bone marrow. It displays many features of autoimmune diseases such as scleroderma, Sjogren's syndrome, and primary biliary cirrhosis. Although many immune abnormalities have been associated with chronic GVHD, the pathogenesis remains unknown. Spontaneous and rapidly induced chronic GVHD in the rat radiation chimera are clinically and histologically distinct from acute GVHD but very similar to chronic GVHD in humans. Using these multiple models, we have begun making progress towards understanding chronic GVHD. Cellular immunopathology studies with monoclonal antibodies show that the target tissues (skin and liver) have a predominance of helper phenotype cells (W3/25). In contrast with acute GVHD, these tissues have a predominance of nonhelper phenotype T lymphocytes (OX8). Within the skin, the helper phenotype cells with chronic GVHD are within the dermis, whereas with acute GVHD the epidermis is infiltrated with nonhelper (OX8+) cells. By comparing the immune abnormalities of the multiple models of chronic GVHD, we have been able to separate some inconsistently present abnormalities from other abnormalities present in all models. Thus, cutaneous IgM deposits and vasculitis appear to be unnecessary paraphenomena, while thymic medullary changes and nonspecific suppressor cells might be pathogenetically important. Current studies are concentrating on defining the necessary antigen discrepancy and tissue location of antigen disparity, the necessary lymphocyte populations, and the relative roles of immune deficiency versus direct immune injury in producing chronic GVHD. (TT)